Characterizing Lung Resident B1 cells and their Impact on Lung Homeostasis during Development

PROJECT ABSTRACT
Tissue resident innate immune cells contribute to lung homeostasis by orchestrating local immunity and
regulating inflammation in a tissue-specific manner. Thus far, characterization of homeostatic mechanisms has
been largely focused on myeloid populations, but the contribution of other innate immune cells to homeostasis
is still in its infancy and requires further inquiry. A population of innate-like B cells, B1 cells, has been critically
implicated in the innate immune response to inflammatory lung diseases and infections. Notably, B1 cells are a
resident immune cell described only in the peritoneal cavity (PeC) and were thought to be recruited to the lungs
during inflammation. In the PeC, B1 cells perform immunoregulatory functions essential for maintaining
homeostasis including spontaneous secretion of large amounts of IL-10 and polyreactive, self-antigen directed
‘Natural’ antibodies (Abs). Recently, B1 cells have been identified as an immunoregulatory resident immune
population in the small intestinal lamina propria (SI-LP). In this tissue, B1 cells comprise half of the plasma cell
pool and secrete IgA to confer mucosal homeostasis. However, the functional role of B1 cells in developing lungs
and contribution to homeostasis remain unknown. Our preliminary studies have identified a transcriptionally
distinct B1-cell subset in scRNA-seq data from embryonic lungs that persists throughout aging. High-dimensional
spectral flow-cytometry confirmed the presence of a phenotypically distinct B1 cell population, expressing the
characteristic markers CD19, IgM, and CD43, in developing lungs and revealed a significant increase in B1 cells
during alveolar development. Further, a subset of B1 cells in the lungs expressed IgA, analogous to B1 cells in
the SI-LP. Thus, we have formulated the central hypothesis that B1 cells constitute a unique lung resident
population with tissue-specific antibody repertoires that contribute to local homeostasis by secreting NAb and
regulating the functions of AMs during tissue development. To test this hypothesis, we will complete a
characterization of resident B1 cells in developing lungs. The experiments in Aim 1 will determine if lung B1 cells
have distinct transcriptional signatures, phenotypic properties, and tissue-specific Ab repertoires compared to
other mucosal and non-mucosal sites. This will be completed using CITE-sequencing, spectral flow cytometry
and Enzyme Linked Immunosorbent Assays from B cells in distinct anatomical locations. Aim 2 will employ
histological techniques and characterization of antibody production in the lungs to investigate whether B1 cells
modulate alveolar macrophage phagocytosis of cell debris and pulmonary surfactant to regulate tissue
homeostasis during lung development. Finally, we will evaluate the lungs of C57BL/6 and Cd19creBtkfl/fl (B1KO)
mice, a B1 cell deficient strain, by flow cytometry and spatial sequencing to determine how B1 cells alter lung
development. This highly impactful study will critically identify how a novel tissue resident B cell population
impacts pulmonary innate immunity with broad implications in lung development and tissue homeostasis.

Public health relevance
PROJECT NARRATIVE Homeostatic mechanisms in the lungs are shaped during early tissue development to critically regulate local inflammation at a barrier site that is constantly challenged. This proposed research will elucidate the novel mechanisms that tissue resident innate immune B1 B cells perform during development that impact the lung environment and the ability of alveolar macrophages, important immune sentinels, to clear debris and maintain respiratory function. This project will describe how a newly discovered tissue resident B cell population performs cell- and antibody-mediated tasks that are essential for the development of lung immunity, thus generating findings that may determine mechanistic pathways driving chronic inflammatory disease when intrinsically or extrinsically dysregulated.